Transcriptional mechanisms of atrial fibrillation

ABSTRACT
Genetic analyses of patients have associated transcription factors (TFs), proteins which regulate gene
expression, with atrial fibrillation (AF). AF is a major healthcare burden with associated healthcare costs
exceeding 26 billion dollars in the US annually. AF exacerbates many forms of heart disease and is among the
leading causes of stroke. Since AF incidence increases with age, the human and financial toll of AF is
anticipated to continue to increase. Current therapies mitigate the consequences of AF, but there are no
therapies that prevent or specifically treat AF. New treatment modalities are urgently needed.
Genome-wide association studies have linked AF to several TFs, among them TBX5. TFs maintain
gene expression programs in healthy cells, and errors in the behavior of the TF network result in inappropriate
levels of gene expression that promote atrial remodeling and AF. Although significant progress has been made
in identifying TFs and downstream targets that comprise the gene regulatory networks (GRNs) of atrial
cardiomyocytes (CMs), many of the regulatory mechanisms of atrial CMs in health and AF remain unknown.
Our preliminary data reveal a previously unappreciated interaction between TBX5 and TEAD1. TEAD1 is a TF
currently best known as a major partner of the transcriptional co-activator YAP1, which regulates cell growth
and responses to mechanical forces through the Hippo signaling pathway. Furthermore, the preliminary data
show that we have successfully generated a murine AF model by inactivating Tbx5 in atrial CMs by delivering
an Nppa promoter-driven Cre recombinase transgene using adeno-associated virus. Building on these results,
here we propose to test the hypothesis that the TBX5-TEAD1 complex maintains rhythm homeostasis in
healthy atria, while the loss of TBX5 causes AF in part by permitting inappropriate transcriptional activation by
pYAP-TEAD1. In Aim 1, we implement biochemical and genetic approaches to determine how TBX5, TEAD1,
and YAP interact to modulate AF pathogenesis. In Aim 2, using TEAD1 ChIP-seq, single nucleus RNA-seq,
and single nucleus ATAC-seq, we will uncover changes in transcriptional regulation that drive AF
pathogenesis.
The proposed research will contribute to our understanding of AF pathogenesis and provide a great
opportunity for the PI to become trained in molecular cardiology and functional genomics approaches to study
gene regulation. Integral to this training, the PI will become well-versed in the latest cutting-edge approaches
and technologies that are essential for an independent career as an investigator. The second aim of the
proposal particularly focuses on obtaining and analyzing NGS data, and the training environment offered by
the Pu lab group (which includes 2 dedicated bioinformaticians) and the affiliated Harvard Medical School
offers a unique opportunity to develop these skills by exploration of the data, supported by didactic training in
the classroom and by collaborative interactions with peers.

Public health relevance
NARRATIVE Atrial fibrillation is the most common serious heart rhythm abnormality and a leading cause of stroke. Currently available treatments have limited ability to prevent or stop atrial fibrillation, in part because the mechanisms that cause atrial fibrillation are poorly understood. This proposal will investigate changes in atrial heart muscle cells that contribute to atrial fibrillation.